National Research Service Award-Medical Scientist

ABSTRACT
Washington University in St. Louis has had a funded Medical Scientist Training Program
(MSTP) for more than fifty years that has evolved into a national source of highly successful
physician-scientists. Herein they present a new application to continue this evolution to train
the next generation of physician-scientists by providing in-depth pre-doctoral training
integrating clinical medicine and biomedical research for individuals desiring careers as
physician-scientists. MD-PhD students are selected from a strong pool of applicants and
comprise an ever-increasingly diverse student body. Medical training is provided by the School
of Medicine and research training is primarily carried out in the interdisciplinary graduate
programs of the Division of Biology and Biomedical Sciences, or in the Department of
Biomedical Engineering. Together, these graduate programs encompass a wide breadth of
biomedical research. The basic components of the training program are: 1) pre-clinical medical
school curriculum with a “MSTP Thread” that explores the scientific evidence for topics covered
in the pre-clinical curriculum, including discussion of primary basic and clinical research
papers; 2) PhD coursework in a biomedically relevant basic science discipline; 3) training in
laboratory safety, responsible conduct of research, and rigor and reproducibility in research; 4)
three or more years of original research, overseen by the training faculty and thesis advisory
committees, leading to completion of a PhD thesis; 5) clinical training; and 6) a wealth of
academic and social programs designed to enhance physician-scientist development and
identity, and train students to think critically, and speak and write effectively. Individual
students are extensively monitored, mentored, and guided. Policies are in place to ensure
training faculty are providing appropriate mentorship. The MD and PhD degrees are awarded
jointly upon successful completion which now averages 8.28 years, a period shortened by
integrating both medical and graduate curricula which are continually evaluated and modified
to enhance student success. The majority of our graduates join the faculty of the nation’s
medical schools while others will contribute to the nation’s biomedical research enterprise in
government laboratories, and the pharmaceutical and biotechnology industries. Regardless of
their career path, their MSTP training will allow them to bridge the gap between the basic
laboratory and the clinic. The success of this program is the product of strong institutional and
NIH support that has allowed us to develop a supportive and effective training environment for
physician-scientists.

Public health relevance
Narrative Physician-scientists advance human health by bringing unique insights and clinical experiences to research on challenging medical problems, but their numbers have been declining for decades. This application seeks funding for an integrated MD-PhD program at Washington University in St. Louis that will educate diverse, well-trained clinician-scientists who accelerate the translation of biomedical research discoveries to the understanding, detection, treatment, and prevention of human disease. Based on a long-established program at this institution, the proposed program is poised to continue to be a national source of physician-scientists.